Identification of antimicrobial specialized metabolites from the human oral microbiome to target multidrug-resistant pathogens

PROJECT SUMMARY / ABSTRACT
Our microbiome plays a key role in colonization resistance, which is the prevention of growth, persistence, and
subsequent infection by pathogenic microorganisms. Disruptions in an established microbial community and its
functioning can alter infection susceptibility. Understanding how changes in the oral microbiome render it
vulnerable to pathogen colonization is essential, as carriage of drug-resistant microbes is a major risk factor for
developing serious and difficult-to-treat infections. One mechanism by which our microbiome acts to prevent
pathogen colonization is through the production of antimicrobial specialized metabolites (ASMs) that directly
inhibit the growth of competing microbes. Identification of such bioactive metabolites can be facilitated by
examining the biosynthetic gene clusters (BGC) that encode them. Analysis of reference genomes generated
through the Human Microbiome Project identified 3,118 BGCs across various body sites, with the typical oral
cavity containing high BGC abundance (1,061+/-143 clusters). The microbiota inhabiting this site represent a
first point of contact with the environment and invading microbes, and therefore, play a vital gatekeeping role
against pathogen dissemination to the lower gastrointestinal and respiratory tracts. Yet, the structure and
function of ASMs produced by human-associated microbiota remains limited, particularly within the oral cavity.
This proposal seeks to leverage a combination of comparative metagenomic and metabolomic approaches to
determine the role of ASM production by oral-associated bacteria in defense against multidrug-resistant
organisms (MDRO). The specific aims are to 1) define differences in oral microbiomes between MDRO
carriers versus non-carriers and assess how determinants of health associate with abundance of key
taxa, and 2) evaluate the production of bioactive ASMs by oral-associated bacteria from MDRO carriers
versus non-carriers. These objectives will be accomplished through shotgun metagenomic sequencing of oral
microbiome samples from diverse populations, paired with analysis of detailed associated metadata relating to
health and MDRO carriage risk factors. Identification of antimicrobial metabolite producing bacteria will be
achieved through high-throughput bioactivity-guided fractionation, followed by metabolomic analysis and in vivo
efficacy testing. The study of ASM production by oral microbiota will yield insight into the factors shaping this
dynamic microbial community and serve as an untapped source for much-needed, new antimicrobial drug leads.
The unmatched caliber of microbiology research performed at the University of Wisconsin-Madison will provide
an ideal environment to carry out the proposed work. Resources and mentorship provided by project sponsor
Dr. Cameron Currie and collaborators will facilitate the timely completion of this proposal. Moreover, execution
of this tailored research training plan will enable the applicant to develop the necessary experimental,
communication, and clinical skills for a successful transition to a career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Multidrug-resistant (MDR) pathogens result in over 2.8 million potentially life-threatening infections in the United States annually. This proposal aims to establish how the microbes naturally associated with our bodies (i.e. our microbiome) protect against difficult-to-treat MDR pathogens. From this work, we will gain a clearer understanding of the factors that render the oral microbiome vulnerable to invading pathogens and will identify promising lead molecules for antibiotic drug development.